SAFETY AND PHARMACOKINETICS OF DIDEOXYINOSINE IN CHILDREN WITH AIDS

This protocol was designed to evaluate the clinical safety, pharmacokinetics and preliminary assessment of efficacy of intravenously and orally administered ddI in pediatric patients with AIDS or symptomatic HIV infection.